How bacterial SMC complexes organize chromosomes

Project Summary
The primary goal of our funded research (R01GM141242) is to understand how the chromosome is organized
and segregated during the cell cycle. We focus on the molecular mechanisms of SMC condensin complex, which
is a key player for chromosome dynamics from bacteria to humans. Our projects combine genetic, molecular,
cytological, and biochemical approaches. The Aim 2 of this grant is to understand the mechanism by which SMC
is unloaded from the chromosome by its unloader, XerD. To address this question, we use purified proteins and
investigate protein-DNA and protein-protein interactions. For our protein purification and protein interaction
assays, a chromatography system is an essential piece of equipment. In the past, we had been using an AKTA
chromatography system in our collaborator Dr Martha Oakley’s lab. However, Dr Oakley has closed her research
lab and this equipment is no longer available to us. Since the biochemical assays are critical to the progress of
my R01 grant, in this application for Administrative Supplements for Equipment, I am requesting funds to
purchase an AKTA chromatography system (and necessary parts) for my own lab. Moreover, this proposed
equipment has features that can expand our biochemical assays and allow us to adapt new methods to advance
the parent grant.

Public health relevance
Project Narrative Faithful segregation of chromosomes underlies genome integrity in all organisms. My R01GM141242 project aims to identify the mechanisms by which broadly conserved structural maintenance of chromosomes (SMC) complexes organize and compact replicated chromosomes in the cell. In this supplement proposal, I am requesting funds to purchase an AKTA pure 25 M Chromatography System and necessary accessories to perform in vitro biochemical experiments proposed in Aim 2.